Admin-Core

PROJECT ABSTRACT
Core A – Administrative Core
The goal of the Administrative Core of the Northwell Roybal Center for Personalized Trials: Physical
Activity Promotion for Persons Giving Care or Living with AD/ADRD is to establish the organizational and
administrative management of the proposed center, as well as ensuring that all relevant expertise is
represented in the Center where needed.
Our Administrative Core will develop and provide the strategic vision, leadership, and the full range of NIH
Stage Model expertise needed for the success of this Roybal Center; monitor Center clinical trials progress
and provide immediate feedback; develop, identify, and use common metrics for Center productivity evaluation
purposes: and finally facilitate collaboration with other Roybal Centers, with the Coordinating Center, with NIA
(National Institute on Aging), and with scientists across the nation interested in advancing the initiation and
maintenance of physical activity regimens personalized to care providers or those living with AD/ADRD.
The overall mission of the Northwell Roybal Center for Personalized Trials is to establish an infrastructure
organized per the NIH Stage Model with scientiﬁc expertise and resources to conduct Stages 0-V trials of the
translational behavioral intervention development pipeline, as well as examining key MoBCs of behavior
change, and so serve as a national resource for the behavioral and social intervention research community in
initiating and maintaining personalized physical activity regimen for caregivers or persons living with
AD/ADRD.

Public health relevance
See attachment in Overall Component, Other Project Information, Narrative